BETA CASOMORPHIN LEVELS IN WITH APNEA OF PREMATURITY

The purpose of this study is to investigate the relationship between Beta casomorphin and the related casein derivative peptides in formula and breast milk with apnea of prematurity.